SAFETY OF GAMMAGARD IGIV GIVIN AT INCREASED RATES AND CONCENTRATIONS

The proposed study is the third and last part of a three phased study. The intent is to sequentially evaluate our agammaglobulinemic patients through each phase of the study. Phase 1, the evaluation of Sandoglobulin (Sandoz) has been completed. Phase 2, the study of Gamimune N (Cutter) is partially complete. The currently proposed Phase 3 will involve Gammagard (Baxter) as the final new product to be developed.